Adoptive T cell Therapy for Patients with NY-ESO-1 Expressing Sarcomas

DESCRIPTION (provided by applicant): The candidate's career goal is to become a principal investigator (PI) of a translational immunology laboratory that will develop immunotherapeutic approaches towards the treatment of patients with advanced sarcoma. In the immediate term, the candidate aims to gain experience as a translational researcher by performing the studies outlined in this proposal. Central to this effort, the candidate will serve as the PI of the phaseI trial examining the use of autologous NY-ESO-1 specific CD8+ T cells for patient with advanced NY-ESO-1 expressing sarcomas in the context of a novel conditioning regimen which incorporates IFNγ. This is a trial that the candidate has written, designed and developed much of the preclinical foundation for. By serving as PI for this trial, the candidate will gain experiece in conducting an adoptive immunotherapy trial, and gain experience collecting and analyzing data from this trial. Additionally, the trial will serve as the platform to initiate multiple labortory-based translational studies investigating mechanisms of immune escape for patients on the trial and strategies to improve successor trials. The trial will be conducted at the Fred Hutchinson Cancer Research Center, an ideal environment for clinical and translational research and a leader in the field of T-cell immunotherapy trials. Dr. Stanley Riddell, an internationally renowned expert in cancer immunology and adoptive T cell therapy trials who is also an experienced and successful mentor, will serve as the primary to mentor the candidate. The candidate has also assembled a mentoring team comprised of senior faculty each with internationally renowned expertise in their particular field of research: Robin Jones (expertise in sarcoma clinical care and clinical trials), Martin (Mac) Cheever (expertise in solid tumor immunotherapy trials) and Cassian Yee (expertise in antigen specific T cell therapy trials). The specific aims of the proposal are as follows: Aim 1: To evaluate in a Phase I trial, the toxicity, persistence and antitumor activity of autologous NY- ESO-1 specific CD8+ cells administered with a novel conditioning regimen incorporating IFNγ, Cyclophosphamide (CY) and low dose IL-2 for patients with advanced MRCL and SS. Aim 2: To evaluate the emergence of antigen loss variants and strategies to broaden the applicability and enhance antigenicity of SS and MRCL patients receiving adoptive T cell therapy. Aim 3: To evaluate strategies to isolate NY-ESO-1 specific CD4+ T-cells for adoptive therapy to enhance or maintain CD8+ T cell function.

Public health relevance
Project Narrative/Relevance This project will provide the opportunity for a clinical researcher-in-training to gain experience running a phase I T cell therapy trial for patients with advanced sarcoma and performing critical patient oriented translational laboratory studies in order to improve future trials. This particular trial will be completely novel in that it will be the first trial ever using autologous NY-ESO-1 specific CD8+ T cells for patients with advanced sarcomas and the first T cell therapy trial to incorporate the drug, interferon gamma. __SpecificAimsTextDelimiter__ Specific Aims The potential to utilize the adaptive T cell arm of the immune system to eradicate human tumors was initially suggested by the graft-versus-leukemia effect of allogeneic hematopoietic stem cell transplant, and now is clearly demonstrated both by the direct transfer of tumor-reactive lymphocytes in melanoma, leukemia, and other malignancies, and by the administration of antibodies that block negative signaling pathways in T cells1-7. Recent reviews of advances in the field of cancer immunotherapy illustrate the potential of this modality to become standard in cancer therapeutics and improve patient survival8-10. The focus of this proposal is to evaluate a novel immunotherapeutic strategy for the treatment of patients with synovial sarcoma (SS) and myxoid/ round cell liposarcoma (MRCL). Studies by the applicant and others have shown that these two sarcoma subtypes express NY-ESO-1, an immunogenic protein that has been successfully targeted in multiple vaccine and T cell therapy trials in melanoma and other diseases11,12. A clinical trial performed by the NCI Surgery Branch treated 6 SS patients with T cells that were engineered to be specific for NY-ESO-1 by retroviral transfer of NY-ESO-1 specific T cell receptor (TCR) genes into autologous PBMC. In this trial, 4 of the 6 patients had partial responses (one lasting up to 18 months) but all patients eventually progressed13. This provocative pilot study illustrates the potential of this approach for the treatment of sarcoma but did not evaluate the mechanisms by which patients who had responded initially ultimately progressed. Studies by the applicant have demonstrated that SS and MRCL tumors frequently have low MHC expression, suggesting that some tumor cells may escape T cell recognition by virtue of low levels of antigen presentation. IFNγ can increase MHC expression on these tumors in vitro, and the applicant has initiated a clinical trial of NY-ESO-1 specific T cell therapy that incorporates low dose, weekly IFNγ into a regimen of high dose cyclophosphamide preconditioning and post infusion low dose IL-2. Surprisingly, this is the first human trial of adoptive T cell therapy to evaluate the potential of IFNγ to enhance and sustain tumor sensitivity to T cell recognition. The trial includes patients with MRCL and uses a clinical grade cell sorting methodology developed by the applicant for the isolation of autologous NY-ESO-1 specific CD8+ T cells. The ability to derive T cell directly from the patient for therapy avoids the problems of poor TCR expression and the potential for TCR mispairing or genotoxicity inherent in retroviral TCR gene transfer. Importantly, the correlative laboratory studies in the proposal will examine mechanisms of success and/or failure of therapy, and preclinical studies will define new targets and strategies that could be applied in future trials to improve efficacy. Specific Aim 1: To evaluate in a Phase I trial, the toxicity, persistence and antitumor activity of autologous NY-ESO-1 specific CD8+ cells administered with a novel conditioning regimen incorporating IFNγ, high dose Cyclophosphamide (CY) and low dose IL-2 for patients with metastatic MRCL and SS. The objective of this trial is to evaluate the safety of the conditioning regimen, the in vivo persistence of infused T cells, and antitumor efficacy. Pre and post treatment tumor biopsies will be obtained to evaluate T cell infiltration into the tumor and whether IFNγ increases MHC expression in vivo. Specific Aim 2: To evaluate the emergence of antigen loss variants and strategies to broaden the applicability and enhance antigenicity of SS and MRCL patients receiving adoptive T cell therapy. The studies in this aim will evaluate the emergence of antigen loss variants in patients enrolled on the adoptive therapy trial in Aim 1 as a mechanism for tumor progression, and test whether antigen-specific T cells targeting additional antigens can be reproducibly generated to overcome this potential problem. Specific Aim 3: To evaluate strategies to isolate NY-ESO-1 specific CD4+ T-cells for adoptive therapy to enhance or maintain CD8+ T cell function. The goals of this aim are to evaluate methods for the isolation of NY-ESO-1 specific CD4+ cells for adoptive transfer that will provide data for an IND application for a future clinical trial in SS and MRCL patients in which targeting NY-ESO-1 and other CT antigens will be targeted with both CD8+ and CD4+ T cells. The initial focus will be on the use of cell sorting with MHC class II tetramers for isolating NY-ESO-1 specific CD4+ cells either directly from patient blood or from populations of T cells that have been expanded in culture.!